Integrative Characterization on the function of COPD GWAS gene, HHIP

Chronic obstructive pulmonary disease (COPD), ranks as the third leading cause of death in the U.S. It is also
strongly influenced by cigarette smoke (CS) and genetic predisposition. HHIP, encoding Hedgehog interacting
protein, has consistently been associated with the susceptibility to COPD including airway remodeling and
emphysema. However, the molecular mechanism underlying this association remains incompletely
understood. Our published work has demonstrated that Hhip heterozygous mice (Hhip+/-) recapitulated multiple
COPD pathological features including smoke- and age-related emphysema and airway remodeling. We also
found that HHIP is highly expressed in Lgr6-expressing airway smooth muscle cells (ASMCs) and Lgr5-
expressing alveolar mesenchymal cells; has reduced expression in COPD ASMCs that display a metabolic
shift from oxidative phosphorylation to glycolysis associated with increased cell growth. Furthermore, alveolar
fibroblasts-derived HHIP promotes proliferation of AT II (alveolar type II) cells in alveolar organoid co-culture
model. These findings suggested that Hhip, the key genetic determinant for COPD, possibly modulates both
airway remodeling and emphysema through complementarily intrinsic and extrinsic signaling in two major lung
mesenchymal cell types: ASMCs and alveolar mesenchymal cells. In this current proposal, we aim to extend
our previous studies by addressing two mechanistic questions related with HHIP: 1) How deficiency of Hhip in
ASMCs promote airway remodeling by increasing airway thickening and cell hyperplasia through metabolic
reprograming and 2) whether and how deficiency of Hhip in alveolar mesenchymal cells have impaired niche to
support AT II cell generation. These questions will be addressed through the combinations of biochemical
assays, lineage tracing, CRISPR-based genome editing and organoid co-culture models. In Aim1, we have
identified a novel interaction between HHIP and PKM2 (pyruvate kinase isozyme M2), a rate-limiting enzyme in
the last step for glycolysis. We will further characterize their interaction in AMSCs as well as determine impacts
of HHIP on CS-induced airway remodeling. In Aim 2, we hypothesize that Hhip deficiency leads to impaired
niche function in Lgr5+ alveolar mesenchymal cells that are important for AT II cells regeneration thereby
determines emphysema susceptibility. To test this, we choose to conditionally deplete Hhip in Lgr5+ cells, a
known alveolar mesenchymal cells marker followed by CS exposure and subsequent measurements on
airspace size, the activity of the Wnt and Hedgehog pathway and proliferation and differentiation of both
alveolar mesenchymal cells (Lgr5+) and AT II cells by complementary approaches in Aim 2.1. In Aim 2.2., we
will use alveolar organoid co-culture model to dissect the mechanism by which Hhip determines niche function
using either murine cells from Hhip deficient mice or from human primary fibroblasts edited by CRISPR/Cas-9
method targeting HHIP. Successful completion of this project will illuminate molecular insights into CS-induced
COPD susceptibility determined by HHIP.

Public health relevance
NARRATIVE Chronic obstructive pulmonary disease (COPD), a major public health problem among aged population, is strongly influenced by cigarette smoking and genetic predisposition. The primary objectives of this proposal are to apply integrative and complementary approaches to characterize functions of a well-replicated gene associated with lung function and COPD in genome-wide association studies (GWAS), HHIP and to define the mechanisms by which HHIP determines susceptibility to airway remodeling and emphysema in two major lung cell types: airway smooth muscle cells and alveolar mesenchymal cells. Investigations on the most significant COPD GWAS gene, HHIP may shed fresh insights into the biological mechanisms on COPD and suggest new pathways for treatment.